Enhancing the International Brain Laboratory's Video Processing Pipeline with Advanced Pose Estimation and Action Segmentation Tools

Project summary/abstract
The International Brain Laboratory (IBL) U19 research program aims to understand how internal states
influence decisions and identify their underlying neural mechanisms in mice. Achieving this goal critically
depends on the rigorous and robust characterization of behavioral states. The IBL employs a modular video
processing pipeline that extracts pose estimates (estimates of the positions of body parts in space) and motion
energy information, and incorporates advanced features like diagnostic plots served back to users via a
centralized dashboard, a versioning system to track model updates, and the flexibility to run on heterogeneous
compute resources. While this robust and scalable infrastructure is state-of-the-art, the individual modules
within the pipeline must be updated to improve accuracy and handle the growing diversity of the video data,
which currently limits detailed behavioral analysis across studies. To address this, I will modernize the video
processing pipeline by incorporating cutting-edge methods: replacing DeepLabCut with Lightning Pose for
more accurate 2D pose estimation, integrating 3D pose estimation for precise tracking of paw movements
using Anipose, and implementing state-of-the-art action segmentation on both 2D and 3D poses to provide
richer behavioral outputs. Each new output will be integrated into existing pipelines for brainwide encoding and
decoding models, ensuring that researchers have access to effective tools for linking these new behavioral
descriptions to neural activity. By updating and integrating these tools into the IBL’s scalable and flexible
infrastructure, this effort will support the U19 research program and advance behavioral analysis across the
IBL network and the broader scientific community.

Public health relevance
Project narrative The International Brain Laboratory (IBL) aims to uncover how internal states influence decisions and identify the underlying neural mechanisms at brainwide scale, but existing limitations in the video analysis pipeline hinder detailed behavioral analyses. This proposal will modernize the IBL’s video processing pipeline by integrating cutting-edge tools for 2D and 3D pose estimation and action segmentation. These upgrades will provide researchers across the IBL network with a richer, more robust description of animal behavior, accelerating discoveries about the neural basis of behavior across the IBL network and beyond.